Maternal milk cytokines activate cognate receptors in the neonatal esophagus to program adult social behavior

Breast milk is superior to baby formula because, in addition to nutrients, it also contains
immunoglobulins and antibacterial substances. Milk has many additional biologically active
substances, including cytokines/chemokines, but their role in infant physical, mental, and cognitive
development is not known. We reported that maternal physical activity during the postnatal period
reduces the level of three cytokines/chemokines, LIF, CXCL1 and CXCL2, in milk that, in turn,
increases the social dominance and reproductive fitness of the offspring. More recently, we
identified the cognate receptors of these cytokines in the epithelioid layer of the neonatal
esophagus, a localization that may explain the behavioral effect of the otherwise labile milk
cytokines, especially in the digestive environment of the lower GI track. We propose experiments
to determine how maternal milk cytokines reach and interact with their target cells/receptors in the
neonatal GI track and signal to alter brain development and adult offspring behavior. The
significance of the proposed work is that it will specify how the neonatal esophagus, an organ not
known for its functional connection to the developing brain, can sense milk borne maternal
cytokines and signal to the brain to alter its development and adult social behavior.

Public health relevance
Breastmilk contains a variety of cytokines (bioactive compounds regulating the immune system and tissue homeostasis), but, given their instability in the gastrointestinal track, it is not clear if they have any immediate or long-term effect on the neonate. We reported that three milk-borne cytokines together influence the social dominance, reproductive fitness, and metabolic health of the offspring. The goal of this application is to specify the target cells and receptors of milk cytokines in the neonatal gut and the nature of their signal that alters brain development and adult offspring behavior.